Quantification of molecular interactions across the matrix spectrum enables cancer research.

Project Summary
We propose to further develop, refine, and validate our emerging free-solution assay (FSA) technology and our
relatively new compensated Interferometric reader (CIR).1,2 The development of FSA-CIR addresses a
significant void, a blind spot in cancer research because it represents the only label-free, solution-phase, ultra-
sensitive, enzyme-free, technology compatible with essentially any matrix. Unlike existing tools, FSA-CIR has
been shown to be useful for; a) mechanism of Action (MOA) studies on unadulterated/unmodified targets and
probes with no relative mass sensitivity, b) full-length membrane protein interaction studies in native matrix, c)
defining allosteric modulation and weak protein-protein interactions, d) accelerating quantitative assay
development, e) potentially addressing biomarker discovery/validation bottleneck, f) performing quantitative
interactions across the matrix spectrum on a single platform and g) enabling ex-vivo measurements to guide
first-in-human dose determinations (FIHD) (see Pfizer letter). FSA-CIR is a paradigm shifting technology based
on a novel molecular interaction transduction method with fluorescence-level sensitivity, and capabilities for
targeting, probing, and assessing molecular and cellular features of cancer biology, as well as improving early
detection and screening, clinical diagnosis. FSA is mix-and-read, agnostic to the molecular interaction pair and
compatible with complex matrices, making it uniquely applicable in both the basic and clinical cancer research
arenas. CIR represents a major advancement in interferometric sensing, due to an unprecedented level of
sample-reference compensation CIR is operated without external thermal control, a unique feature for a
refractive index (RI) sensor with <10-7 RIU sensitivity. The optical engine in CIR is unique, patented and quite
simple, consisting of a diode laser, capillary tube, mirror and detector. When combining the interferometer with
a droplet generator for sample introduction, CIR facilitates quantification of molecular interactions without relative
mass dependence, at picomolar sensitivity and allows good sample throughput (50 serum sample-reference
pairs run in quintuplet, [5 replicate droplet pairs], plus calibrations in a day. Feasibility of our assay methodology
is demonstrated for mechanism-of-action (MOA) studies, quantification of drug target engagement as needed in
theranostics and ultrasensitive, volume constrained, biomarker assay development, and target quantification.
Data indicate FSA-CIR has the potential for widespread applicability and adoption throughout the scientific
community and is mature enough to be an R-33 project. At project completion we aim to provide the scientific
and medical community with a user-friendly platform technology for biochemical mechanism of action studies, to
aid in improving cancer prognostics, and the ability to measure properties such as molecular and/or cellular
mechanisms important in cancer.

Public health relevance
Public Narrative Under this project, we will further develop and validate an emerging platform technology that can be used to measure molecular interactions, in complex matrices, such as serum and urine, without altering the sample and at unprecedented sensitivity. Preliminary observations indicate that the Mix-and-Read, free-solution assay methodology can be used widely, with the potential to accelerate and/or enhance research in the areas of drug discovery, cancer biology, early detection and screening, and clinical diagnosis.